Spatial single-cell profiling to identify tumor-immune-bone niche features in HER2-low bone metastasis in response to T-DXd treatment.

Project Summary/Abstract
Building upon the parent CSBC U01 project that investigates the role of bone mesenchymal stem/stromal cells
in fostering the early outgrowth of disseminated tumor cells, this supplement project expands to unravel tumor-
immune cell interactions in clinically advanced bone metastases, particularly focusing on HER2-low breast
cancer resistance to T-DXd treatment. HER2-low breast cancer accounts for 45–55% of all breast cancer
cases, and bone metastasis is more common in this subtype than others. Novel HER2-directed antibody-drug
conjugate (ADC) agent, trastuzumab deruxtecan (T-DXd), has shown antitumor activity in HER2-low tumors.
However, a significant portion of patients showed de novo resistance. Surprisingly, 25% of the HER2-zero
cohort showed measurable objective response. These findings suggest the involvement of additional factors
beyond HER2 expression levels in determining T-DXd response and/or resistance. Our preliminary study,
using NanoString GeoMX spatial proteomics, in investigating eleven bone metastasis patients’ samples (4
responders vs. 7 non-responders to the T-DXd treatment), highlighted a complicated correlation between
various immune features and T-DXd treatment responsiveness. In this project, we will employ the CosMX
single-cell 6,000-plex mRNA and 64-plex protein platform to profile the bone metastasis niche, leverage the
MD-SPACER computational tool developed from the parent U01 project to analyze cell-cell/cell-niche
interactions and the Wong lab's S2C2 tool to model spatial cell-cell crosstalk intracellular and intercellular
signaling. This project marks a new collaboration between Wong’s team and Dr. Bill Li, a clinical pathologist
from the Emory Winship Cancer Institute, and Dr. Wenjuan Dong, an immunologist at the Houston Methodist
Cancer Center. Neither Li nor Dong is funded by any CSBC program. In addition, this project will involve two
MD/PhD trainees who will gain hands-on experience in spatial omics experimentation and analysis.

Public health relevance
Project Narrative This new collaborative project focuses on integrating the parental U01-developed computational tools with single-cell spatial transcriptomic/proteomic data generated from clinical bone metastasis tissue samples to explore why HER2-high tumors may not respond to T-DXd and why HER2-zero tumors can respond.